Kruppel-like factor-2 CD4+ T cells and intestinal inflammation

Abstract Mucosal tissues like the intestine harbor trillions of antigenically foreign microbes. Unavoidable
approximation with commensal microbes in this context highlights the need for expanded peripheral immune
tolerance. However, fundamental gaps in knowledge remain as to how this physiological imperative is
achieved. Filling these knowledge gaps have enormous potential to reveal novel insights on the immune-
pathogenesis of inflammatory bowel disease and other human autoinflammatory disorders. Our current
framework for investigating how tolerance expands to accommodate commensal intestinal microbes is
primarily focused on the FOXP3+ suppressive subset of CD4+ T cells called regulatory T cells (Tregs).
However, several inconsistencies also highlight the limitations attributing commensal tolerance exclusively to
FOXP3+ cells. With these considerations, our preliminary studies pivoted to investigate commensal specific
CD4+ T cells, without a FOXP3 bias, using an instructive model whereby CD4+ T cells with commensal
specificity can be precisely identified. Using recombinant Candida albicans to establish intestinal colonization
and tracking endogenous CD4+ T cells with MHC class II tetramers, our initial analysis of gene expression
profiles (single-cell RNA-seq) shows minimal (<5%) Treg differentiation amongst CD4+ cells with commensal
specificity. Instead, RNA profiling showed nearly half of peripheral cells that expand in response to commensal
stimulation are not classified based on expression of other lineage-defining markers, and unified by expression
of the zinc finger transcription factor Kruppel-like factor-2 (KLF2). Antigen-experienced KLF2+ CD4+ T cells are
further shown to potently suppress responder T cell proliferation during in vitro co-culture. The necessity for T
cell expressed KLF2 is further highlighted by spontaneous intestinal inflammation that develops in mice with
conditional KLF2 deficiency in T cells, or the rapid (within 10 days) onset of disease in mice with induced
KLF2-deficiency in CD4+ cells. Intestinal inflammation that occurs in the absence of KLF2+ CD4+ T cells is
triggered by commensal microbes since their elimination using a cocktail of antimicrobials averts intestinal
inflammation, efficiently bypassing the necessity for T cell expressed KLF2. Thus, our overall hypothesis is that
KLF2 identifies a FOXP3-negative immune-suppressive subset of CD4+ T cells essential for sustaining
tolerance to intestinal microbes. Three inter-related aims designed to further develop this potentially ground-
breaking hypothesis are proposed which include establishing the molecular basis for how KLF2+ CD4+ T cells
mediate suppression, and whether KLF2 is necessary and/or sufficient to promote functional suppression (Aim
1), the molecular basis for how KLF2+ CD4+ T cells protect against intestinal inflammation in vivo (Aim 2), along
with gene expression, chromatin accessibility, and KLF2 DNA binding distinctions between KLF2+ CD4+ T cells
compared with FOXP3+ Tregs, and other CD4+ T cell differentiation subsets in intestinal and lymphoid tissue
as a basis for their unique biological functional properties (Aim 3).

Public health relevance
Intestinal disorders including Crohn’s disease, ulcerative colitis, and irritable bowel syndrome are increasingly linked with aberrant commensal microbe driven inflammation. This application will investigate how the immune system recognizes and responds to commensal microbes to achieve immunological homeostasis that protects against aberrant intestinal inflammation.